Tissue and neurobehavioral phenotyping core

PROJECT SUMMARY
The Tissue and Neurobehavioral Phenotyping Core, designated as Core C, is a centralized facility that will
provide investigators with a well-established and reproducible model of influenza A–induced pneumonia.
Quantitative tools such as Flexivent measurements of lung mechanics, magnetic resonance imaging to
evaluate lung repair and remodeling, and multiplex measures of pro-inflammatory cytokines will be conducted
by Core C according to the research plan outlined in Projects 1, 2, and 3. Core C will use advanced flow
cytometry capabilities to quantify, phenotype, and sort specific inflammatory and parenchymal cell populations
from the murine lung, brain, and muscle. The sorting and isolation capabilities of the Core will allow cell-type-
specific assessment of proteostasis networks via mass spectroscopy (as outlined by Core B). Core C will
breed mice to generate the cell-type- or tissue-specific Cre recombinase lines to induce tissue-specific
knockout mice. Core C will perform the genotyping of all the murine strains proposed by Project Leaders. Core
C will maintain a uniform environment in which wild-type and genetically engineered mice will be aged.
Importantly, Core C will assess the impact of influenza A–induced pneumonia on age-related changes in
neurobehavioral phenotypes. Briefly, Core C will examine motor coordination and balance by means of an
accelerating rotarod test. Response latency on a hot plate will be tested to assess nociceptive functions.
Exploratory behaviors and locomotor activity will be examined in an open field assay and by continuous
monitoring with running wheels. Learning and memory will be examined in novel object recognition and Barnes
maze tests. Collectively, these tools provide a unique resource for Project Investigators, which would be
difficult to reproduce without the support of this PPG.

Public health relevance
PROJECT NARRATIVE It is not required per instructions stated on the Funding Opportunity Announcement PAR-18-297, Section IV. Application and Submission Information, Project, Research & Related Other Project Information (Core), “Project Narrative: Do not complete”.